Data Core – Improving Provider Announcement Communication Training (IMPACT)

ABSTRACT – Data Core
The Data Core will centralize data-related services across research projects for the P01 Program Project,
“Improving Provider Announcement Communication Training (IMPACT),” at the University of North Carolina.
The IMPACT Program Project will make a significant contribution to cancer prevention by developing new
evidence on effective strategies to improve provider communication and human papillomavirus (HPV) vaccine
uptake. Drs. Justin Trogdon and Nisha Gottfredson will be the co-leads of the Data Core. The Data Core’s
functions include managing a national primary care team survey, cleaning and standardizing effectiveness data
across research projects and providing statistical support for randomization and analysis. The three Specific
Aims of the Data Core are as follows. Aim 1 is to develop, oversee, and manage the national primary care
team survey. The Data Core will survey 2,500 primary care team members: 1,500 HPV vaccine providers
(physicians, physician assistants, and nurse practitioners) and 1,000 registered nurses and medical assistants
involved in adolescent vaccination. The Data Core will be responsible for coordinating and integrating survey
measures for use across projects, collaborating with the survey subcontractor to oversee survey
implementation, and managing and preparing data for use by the research projects. Aim 2 is to facilitate
access to, and standardize the structure of, large vaccination datasets generated by research project
randomized clinical trials. The Data Core will be a central hub for managing, harmonizing, storing, and
distributing randomized clinical trial vaccine outcomes data that will be used to evaluate intervention impact
across Projects 1 through 3. The Core will also provide the resulting data to Project 4 to support budget impact
and cost-effectiveness modelling. Aim 3 is to provide statistical and methodological support to research
projects. The Data Core team will connect project investigators with appropriate statistical and study design
expertise to design and consult on analyses as needed by the research projects. The Data Core activities will
result in a national primary care team survey, high-quality, standardized data and appropriate and rigorous
statistical analysis in an efficient manner that will increase the collective scientific impact of the P01 Program
Project. The Data Core addresses the IMPACT Program Project theme by helping the research projects to
build capacity for HPV vaccine communication interventions among primary care teams in healthcare systems.

Public health relevance
NARRATIVE – Data Core The Data Core will centralize data-related services across research projects for the P01 Program Project. The Data Core’s functions include managing a national primary care team survey, cleaning and standardizing effectiveness data across research projects and providing statistical support for randomization and analysis.